Dissecting the mechanisms behind biphasic beta cell disease caused by mutations in HNF1alpha

Project Summary
In order for the b-cell to precisely secrete insulin in response to glucose, glucose metabolism to ATP is
tightly coupled to insulin secretion through the ATP-sensitive K (KATP) channel. Any disruption along this
pathway leads to b-cell dysfunction and ensuing diabetes or, more rarely, congenital hyperinsulinism. While
these diseases mostly arise from multiple factors, some cases are caused by single gene mutations, termed
monogenic diseases. Interestingly, the same loss-of-function heterozygous mutations in the transcription factor
HNF1a can result in both hyperinsulinism and diabetes, though presenting at different ages and through
unknown mechanisms. In the proposed project, we will investigate the underlying causes of both HNF1a-
related diabetes and hyperinsulinism. Our prior published work and additional preliminary data show that
HNF1A-deficient human stem cell-derived β-cells exhibit increased basal and decreased glucose-stimulated
insulin secretion, recapitulating the clinical disease. HNF1A-deficient β-cell models exhibited significantly
decreased glycolysis, suggesting decreased ATP production in response to glucose. Expression analyses
revealed broad defects in HNF1A-deficient β-cells in genes regulating cellular metabolism and decreased
expression of KATP channel genes. Based on these previous findings, we hypothesize that HNF1a regulates
both KATP channel expression and ATP production in response to glucose. Loss of HNF1a leads to uncoupling
of glucose metabolism and insulin secretion at these two points in the insulin secretion cascade, impacting
basal and stimulated insulin secretion in opposing directions and resulting in hyperinsulinism and diabetes,
respectively. Using a novel and manipulatable human b-cell model system combined with a variety of analytical
techniques, we will rigorously test our hypotheses and advance our knowledge of b-cell dysfunction in complex
disease states.
My long-term goal is to have a basic and translational research lab that studies the diseases resulting
from pancreatic β-cell dysfunction. My proposed K08 project will help me learn new technical methods,
develop a new intellectual foundation and generate preliminary data that will be instrumental in helping me
start my own independent lab. I chose my co-mentors as they have complimentary research approaches and
varied areas of expertise. I have a career development plan which relies on my extensive mentoring
relationships, including regular interaction with my co-mentors and my advisory committee, which contains
individuals within the local and national research community with varying areas of expertise. I have developed
a plan of training which takes full advantage of the collaborative research environment at the Children’s
Hospital of Philadelphia and University of Pennsylvania School of Medicine, including participation in trainings,
seminars, and workshops to advance my knowledge base and professional skills.

Public health relevance
Project Narrative The role of the pancreatic b-cell is to secrete insulin in response to glucose. Defects in this process can result in inadequate insulin secretion causing diabetes or excessive insulin secretion causing hyperinsulinism. The goal of this project is to understand how the same mutations in the transcription factor HNF1a can cause both of these opposing diseases through disruption at different points along the insulin secretion cascade.